Neural circuit control of sighing

Proposal Summary
Breathing is a vital process that maintains oxygen and carbon dioxide homeostasis, and its dysregulation leads
to various and often devastating conditions. Effective pharmaceutical treatments for patients in respiratory
abnormalities are severely limited due to our lack of knowledge on the neurological mechanisms controlling
breathing and how they may go awry under pathological conditions. Sighs are long, deep breaths with a
bimodal inspiration that occur spontaneously every several minutes to reverse the alveolar collapse
(atelectasis) and maintain normal lung function. Sighing has also been implicated in various pathological
conditions, including sudden infant death syndrome. The long-term goal of my laboratory is to understand the
neural control of breathing patterns, including sighing, and how it fails in pathological conditions. In this project,
we propose to understand how the central control mechanism of sighing is regulated by physiological sigh-
inducing stimuli, including hypoxia and sleep-wake states. We recently identified that the mouse brainstem
neurons expressing neuromedin B (Nmb) or gastrin releasing peptide (Grp) comprise the core components of
a dedicated sigh control circuit. Leveraging this endogenous pathway and circuit underlying sighing, we will
integrate mouse genetics, optogenetics and chemogenetics, genetic ablation, neural circuit tracing, functional
imaging, and physiological assays, to genetically and functionally dissect the neural control circuits in mouse in
vivo experiments. In Aim 1, we will use optogenetics, genetic ablation, and circuit tracing to define the neural
circuit underlies hypoxia-induced sighing. In Aim 2, we will examine the role of input neurons to the sigh circuit
in regulating sighing as a function of sleep-wake state. In Aim 3, we will monitor the calcium activity of the sigh
control neurons during basal and induced sighs in order to understand the neuronal basis underlying the
generation of sighing and other breathing patterns in physiological conditions. The expected outcomes are to
lead to a better understanding of the function of the sigh control circuits, and provide an improved foundation
for understanding how different breathing patterns are controlled and how physiological states in turn dictate
switches in the breathing patterns. These outcomes will have an important impact by revealing the mechanistic
basis for the pathophysiology of breathing disorders and identifying targeted pharmacological approaches for
new treatment modalities in a variety of clinical scenarios.

Public health relevance
Proposal Narrative Sighs are long, deep breaths essential for life by preventing lung collapse, and are regulated by hypoxia and sleep-wake states. The proposed studies will reveal the neural mechanisms of sighing in response to physiological conditions, and how these inputs are integrated. This work will provide novel insights on the neural basis of breathing pattern generation, and pave the way for developing targeted pharmacological treatments for breathing abnormalities.